Optimal Dosing of Understudied Drugs Administered to Pregnant Individuals per Standard of Care (PregDose)

PROJECT SUMMARY/ABSTRACT
The majority of drugs prescribed to pregnant individuals lack dosing information specific to this population.
Dosing is different in this population due to anatomic and physiologic changes during pregnancy that
substantially affect drug exposure. A lack of appropriate dosing data in pregnant individuals is an unmet public
health need that can result in therapeutic failure and maternal and fetal morbidity. Our objective for the Dosing
and Safety of Understudied Drugs Administered to Pregnant Individuals per Standard of Care (PregDose)
Study is to create the research infrastructure to address these dosing knowledge gaps and determine optimal
dosing for commonly used drugs in pregnancy. We will accomplish this goal through an integrated approach
that is centered on a prospective, multi-center, opportunistic study of understudied drugs in pregnant
individuals. In AIM 1, we will enroll pregnant individuals who are on a drug(s) of interest per standard of care.
Biological samples and markers of drug efficacy will be collected throughout pregnancy and in the postpartum
period. Postpartum samples will also include cord blood and infant blood to better understand fetal/neonatal
exposure. Using an aliquot of each sample, in AIM 2 we will establish a biorepository to aid future precision-
dosing studies. In AIM 3 we will use sophisticated pharmacokinetic (PK)-pharmacodynamic (PD) modeling to
determine optimal dosing. This modeling will identify key determinants of drug exposure-effect to inform a
pregnancy precision dosing tool. The PIs and research team have a successful history in maternal
pharmacology and possess the skills, access to patients, and research environment needed to complete these
projects. Dr. Rebecaa Clifton is a biostatistician, the PI of the Maternal-Fetal Medicine Units (MFMU) Data
Coordinating Center and will oversee all study efforts. Dr. Watt is a pediatrician, experienced trialist and
pharmacologist, serves on the PRGLAC Implementation Working Group, and has led similar opportunistic
dosing studies in children and lactating individuals. Dr. Torri Metz is a maternal fetal medicine specialist with
extensive experience in obstetric drug trials. Importantly, this study will leverage the infrastructure and
resources of the NICHD-funded MFMU Network and Maternal and Pediatric Precision in Therapeutics
(MPRINT) Hub. Key MPRINT co-investigators have the expertise and resources to develop the assays to
measure drug concentrations (Momper), support the PK-PD modeling (Quinney, Momper, Bies), and develop
the model-informed precision dosing tool (Quinney, Bies). To maximize scientific exchange and accelerate
research in the field, all information, data, protocols, resources, and methods developed by PregDose will be
shared through the MFMU and MPRINT Hub and with the research and clinical community at large.

Public health relevance
PROJECT NARRATIVE For decades, pregnant individuals have been largely excluded from clinical drug trials. As a result, the vast majority of drugs used in these populations are prescribed off-label with scant data to guide dosing. The Dosing and Safety of Understudied Drugs Administered to Pregnant Individuals per Standard of Care (PregDose) Study will address this key knowledge gap by combining novel approaches to trial design, a national biorepository with comprehensive drug information, and sophisticated pharmacokinetic modeling to determine precision dosing in pregnancy.